SBIR N34DA-19-1232

This project will support the viability of telemedicine treatment for MAT, allowing Workit Health and other telehealth MAT services to expand their outreach. With increased use of telehealth, more individuals with opioid use disorder will be able to access the most effective known treatment.